Administrative Core

PROJECT SUMMARY/ABSTRACT
The current Center proposal, entitled “Systems Epigenomics of Persistent Bloodstream Infection” represents a
synergistic approach to understanding the host-pathogen interactions that result in life-threatening bloodstream
infections that do not clear on appropriate therapy. A highly innovative and expert team has been assembled to
implement a systems-biology strategy that is ideally aligned to achieve NIH / NIAID priorities. A diverse set of expertise,
technologies and activities are necessary to efficiently reach our objectives. To effectively manage this integrated
research program, we will implement our proven Administrative Network Core (ANC) to interact with each Project and
Core. Thus, synergistic collaboration, research efficiency and discovery will be enhanced. The ANC design will afford
highly efficient coordination among investigators and Center components, including Projects 1–3, and our Immunomics
& Epigenetics (IEC), Bionformatics & Data Management (BDM) and Computational & Predictive Modeling (CPM) Cores.
Coordination with Collaborators and Consultants by the ANC further amplifies the programmatic strengths of the Center. The
ANC will provide a supportive infrastructure to ensure accomplishment of all Center goals: 1) managing the project
financial and personnel resources; 2) facilitating coordination and integration of research Projects, Cores and Advisors;
3) ensuring quality improvement by monitoring of benchmark metrics and logistical optimization; 4) overseeing the
solicitation, review, selection and monitoring of Supplemental Research Projects; and 5) promote a positive research
environment that is equitable, inclusive and diverse. Thus, the ANC will support the overall Center to inform, coordinate,
monitor and advance timely completion of all research goals.